Connecting the universe of proteins to address annotation inequality in the microbial proteome

Principal Investigator (Wright, Erik S.)
Abstract:
The rapidly increasing number of microbial genomes has revealed an enormous diversity of proteins without
any known function. We still know relatively little about over half the proteins encoded in a typical bacterial
genome, and traditional laboratory techniques are too time consuming to characterize even a small fraction of
the observable universe of proteins. This neglected "dark proteome" potentially contains many important
determinants of virulence, antibiotic resistance, and disease. Casting a light on the dark proteome is possible
through comparative genomics because proteins interacting across evolutionary timescales leave behind a
signature of coevolution that can be used to connect proteins of unknown function with proteins of known
function. This 'guilt-by-association' analysis helps to generate hypotheses about the cellular role of unexplored
proteins. Here, we develop novel methods for quantifying coevolutionary signals, and we apply these methods
to an unprecedently large collection of genomes spanning the microbial tree of life. This project will result in a
network of coevolving genes that we will make publicly accessible as a web tool for biomedical research. To
further harness the power of comparative genomics, we will develop and deploy web applications that provide
deeper insights into the universe of microbial proteins.

Public health relevance
Principal Investigator (Wright, Erik S.) Project Narrative: Genomes harbor an immense amount of untapped information that could provide valuable insights into the interactions and functions of genes within cells. This work will develop a network of coevolving genes spanning many different microorganisms and make it publicly accessible as an online tool for biomedical research.